Interaction of Choline and Fat in the Prenatal Programming of Nonalcoholic Steatohepatitis

Summary
Nonalcoholic steatohepatitis (NASH), characterized by hepatic triglyceride accumulation and inflammation,
is a growing public health problem that affects about 7% of the U.S. population. It is hypothesized that maternal
obesity exerts the first metabolic hit to the fetal liver, priming it for fat accumulation and increased susceptibility
to NASH, whereas a postnatal obesogenic environment imposes further hits that result in NASH. In this proposal,
we will use choline, a semi-essential nutrient, to prevent the prenatal programming of NASH. Choline
plays an important role in lipid metabolism, facilitating hepatic lipid export and serving as a methyl donor which
modifies expression of lipid metabolic genes via an epigenetic mechanism. Prior research of our lab suggests
that maternal choline supplementation (MCS) in obese mouse dams prevented excess triglyceride accumulation
in the fetal liver partly by increasing the DNA methylation of the lipogenic gene Srebf1 and improved blood
glucose homeostasis in early adulthood. MCS also increased the abundance of long-chain polyunsaturated fatty
acids (LC-PUFAs) containing plasmalogens, a group of phospholipids that serve as sacrificial antioxidants, in
the offspring. Since the NASH liver is characterized by oxidative stress and LC-PUFA deficiency, MCS may
mitigate these risk factors of NASH. Interestingly, the beneficial effects of MCS was more prominent in offspring
whose dams also received high-fat (HF) feeding during gestation, suggesting an interaction between choline and
HF feeding. The objective of this study is to determine the interactive effect of CS with dietary fat on preventing
the prenatal programming of NASH. The overarching hypothesis is that prenatal and postnatal CS would
ameliorate NASH development initiated by a maternal HF, obesogenic diet; CS would synergize with LC-PUFA
supplementation to further prevent the prenatal programming of NASH. In Aim 1, we will determine the effect
of lifelong choline supplementation (CS) on preventing the prenatal programming of NASH by HF feeding.
Offspring mice born to HF-induced obese dams will receive a HF, high-fructose Western style diet (WD) post-
weaning to trigger NASH. Choline will be supplemented at different life stages to discern its effect by timing of
intervention during the prenatal period (first hit), postnatal period (later hits), or both (first and later hits). We
will use stable isotope tracing to discern the preferential partitioning of choline into its metabolic fates as
phosphatidylcholine or betaine, thereby influencing the hepatic lipidomic profile and epigenetic regulation later
in life. In Aim 2, we will determine the effect of CS and LC-PUFA co-supplementation on NASH prevention.
Both mouse dams and offspring will receive a fish oil supplemented HF or WD diet as well as CS. We will
compare the joint effect of fish oil and CS on NASH characteristics and lipidomic profile. This study will provide
proof-of-concept evidence for the use of choline alone or in combination with LC-PUFA as a cost-effective and
innocuous prophylactic agent for NASH programmed by prenatal and postnatal HF, obesogenic diet exposures.

Public health relevance
Project narrative Maternal high-fat feeding during pregnancy and lactation predisposes the offspring to higher risk of developing non-alcoholic steatohepatitis (NASH). This project investigates the interacting effect of prenatal and postnatal choline supplementation with dietary fat on preventing the prenatal programming of NASH. This study will provide proof-of-concept evidence for a cost-effective and noninvasive prophylaxis for NASH, dissociating the maternal obesogenic environment with adverse health consequences in the offspring.